Institutional Career Development Core

I. INSTITUTIONAL CAREER DEVELOPMENT CORE – KL2 PROGRAM: ABSTRACT
The Harvard Catalyst (HC) KL2 Program is the cornerstone across Harvard University (HU) and its affiliated
academic health centers (AHCs) to train the future leaders in clinical and translational research. The KL2
program admits, by a highly competitive process, CT investigators who are within the first 3 years of their initial
faculty appointment at HU. Over the period of this award, to meet CTSA requirements and budget reductions,
the HC KL2 program will admit 14 awardees in year 1, 13 awardees in year 2, 10 awardees in year 3, and will
reach the 9 allowable slots by year 4.
Each KL2 awardee will be enrolled for a period of two years to allow him/her to acquire by the end of the award
period: 1) Subsequent peer-reviewed funding from the NIH or disease-specific foundation grants, and 2)
Further support and acknowledgement at their AHCs as CT investigators who are critical to the institutional
mission as documented by financial support and a clear track for promotion. These are the two key metrics of
success of the HC KL2 program. To accomplish this, the KL2 program will create a community for junior CT
investigators to enhance their transition to independence.
The KL2 Program proposes four specific aims: (Aim 1) Select, mentor, and train HC KL2 trainees, and provide
a supportive Harvard-wide environment that ensures their success, and develops and sustains a robust
community of junior CT research investigators; (Aim 2) Optimize and individually tailor a customized
educational program that supports the training of KL2 trainees so that they become independent, collaborative,
and team science-based investigators committed to combating the most complex human diseases and health
problems; (Aim 3) Evaluate and continuously improve individual and team mentorship models that support
successful development and career progression of diverse HC KL2 trainees; and (Aim 4) Ensure that metrics
of success are continually used to identify and improve components of the program that most effectively
support career progression and transition of KL2 awardees to independence. These aims will be completed
with the contributions of outstanding faculty mentors, HC Cores that enhance education and research
methodology, and innovative HC programs that encourage team science and ensure a diverse workforce. KL2
graduates will become fully independent CT investigators capable of addressing unmet medical needs, and in
turn, training the next generation of CT investigators.